Admin Core

THE HARC CENTER: HIV ACCESSORY AND REGULATORY COMPLEXES
ADMINISTRATIVE CORE Lead: Nevan Krogan; Co-Lead: Lorena Zuliani-Alvarez
SUMMARY
The mission of the Administrative Core is to support and promote the scientific and collaborative goals of the
HARC Center. The Core will provide leadership that ensures strong oversight and representation of all
stakeholders in decisions, facilitate the integration of research projects, and connect the HARC Center to the
broader NIAID Centers for HIV Structural Biology. Day-to-day activities will be coordinated by a team co-lead by
the HARC Center Director (Dr. Nevan Krogan), who has extensive experience leading and managing large
research centers, and the Administrative Core Co-Lead (Dr. Lorena Zuliani-Alvarez). They will be supported
by the UCSF Quantitative Biosciences Institute (QBI) administrative team. Evaluation of progress toward the
Center’s goals as well as budgeting and long-term planning of center activities will be performed by the HARC
Center Executive Committee (EC), consisting of the Director, Project Leads (Drs. Gross, Marson, and Frankel)
and the co-Lead of the Administrative Core (Zuliani-Alvarez). As a first task of the Executive Committee, a
Scientific Advisory Board (SAB) will be formed to review the Center’s progress and future plans. The
Administrative Core will organize and manage a number of regularly scheduled meetings for the EC, the entire
HARC Center, and the wider HIV research community to facilitate communication amongst members and provide
ample opportunities to discuss overall research directions and specific experimental concerns. In collaboration
with the Developmental Core, the Administrative Core will maintain the HARC Center website (harc.ucsf.edu)
and shared file servers. To provide formal site review and involvement with NIAID staff, the Core will organize
an annual SAB Meeting, in which the PIs and key personnel will meet with the SAB and NIAID program staff to
review the Center’s activities. The HARC Center’s outreach activities and efforts to increase diversity, equity,
and inclusion (DEI) will encompass workshops, podcasts, and internships for URM students and will be
supported by the QBI Media & Events team.